CORE--SMALL ANIMAL IMAGING

Specialized Resource 3-Small Animal Imaging Resource (Dr. Levin/Moseley Co-Pi's): This resource provides access to all the small animal imaging instruments used by all current and future ICMIC at Stanford investigators. The ability to use a multimodality imaging approach to solve a biological problem of interest with bioluminescene and fluorescence optical imaging, small animal computed tomography (microCT), micro positron emission tomography (microPET), micro single photon emission computed tomography (microSPECT), digital whole body autoradiography (DWBA), small animal high-resolution ultrasound, and small animal magnetic resonance imaging (MRI) are all key components of this resource. The ability to utilize multimodality small animal imaging instruments and to have expertise available to evolve these technologies and their uses are a key feature of this important resource. All Research and Developmental Projects will utilize this resource.